Imaging of HTLV-1 by cryo-CLEM

RESEARCH PROJECT
Abstract
Human T-cell leukemia virus (HTLV-1) has been estimated to infect 15-20 million individuals worldwide and is
known to be the etiological agent of an adult T-cell leukemia/lymphoma (ATLL), an inflammatory disease
syndrome known as HTLV-1-associated myelopathy/tropical spastic paraparesis (HAM/TSP), and pathologies
of the lung, skin, eyes, and thyroid gland. HTLV-1 is notorious for being extremely difficult to propagate in cell
culture, which has prohibited rigorous analyses of virus replication, including the steps involved in retrovirus
assembly. HTLV-1 spread is known to be heavily reliant on virus infection involving cell-to-cell contacts that form
what is termed the virological synapse (VS), which represents the primary means for virus spread, including
events associated with oral transmission. While HTLV-1 has been previously studied in regard to virus spread
via cell-cell contacts, a significant knowledge gap exists regarding the nature of virus particle assembly and
transmission via the VS. In general, virus particle spread through cell-cell contacts increases the likelihood of an
infection event of virus particles that may possess low particle infectivity in cells without formation of VS. Previous
studies have indicated that a low proportion of mature HTLV-1 particles possess an intact capsid core,
suggesting that aberrant particle morphology could help to explain the poorly infectious nature of cell-free HTLV-
1. In order to address the current knowledge gap in the field, we propose in this exploratory application to develop
workflows for state-of-the-art bioengineering and quantitative imaging technologies that hold high promise in
being applied to the efficient study of HTLV-1 particle assembly and spread at the VS. First, we will develop a
workflow for the use of cell micropatterning technology in order to reproducibly and efficiently create cell-cell
contacts and investigate the role virus budding in virus spread. Second, we propose to establish an efficient
workflow in which we can view cell-cell contacts utilizing high-resolution cryo-correlative light and electron
microscopy in order to investigate the role of host cell proteins in virus assembly at cell-cell contacts.
Development of these workflows will allow for quantitative analysis of virus particle biogenesis at cell-cell
contacts. These technologies have broad applicability in virology and the success of this research will be
applicable to a variety of questions regarding virus replication and virus-host cell interactions.

Public health relevance
Relevance Narrative Human T-cell leukemia virus type 1 (HTLV-1) is a cancer-causing human retrovirus that infects about 15-20 million individuals worldwide. While virus particle assembly at cell-cell contacts are required for efficient virus transmission (both within and between individuals), many fundamental aspects involved in this critical mode of virus spread are poorly understood, including the nature of virus spread and particle morphology of released particles. Development of experimental workflows to enable new cutting-edge technologies will improve understanding of this distinct mode of virus transmission, which has broad relevance to other viruses capable of spread via cell-cell contacts – including transmission events.